Administration Core

The P30 Core Center requires administrative assistance beyond that provided by indirect costs. The Administrative Core supports the Core Center PI, Peter G. Gillespie, for management. In addition, the Administrative Core supports the activities of an Administrator and an Accountant, who manage the day-to-day administrative load of the Core Center.